Regulators of The Unfolded Protein Response Signaling

Project Summary/Abstract:
The endoplasmic reticulum (ER) provides the platform for protein folding and secretion. In
cases when proteins fail to fold correctly or misfold, they accumulate inside the ER, leading to the
activation of a signaling network known as the unfolded protein response (UPR). This response
involves three major ER-resident sensors: activating transcription factor 6 (ATF6), inositol
requiring enzyme 1 (Ire1), and protein kinase RNA-activated-like ER kinase (PERK).Each sensor
activates a distinct signaling pathway that leads to the activation of specific transcription factors,
which are responsible for the activation of genes encoding protein-folding enzymes. These
coordinated processes enhance the protein-folding capacity of cells.
Emerging
biological data, such as transcriptome, proteome and interactome information,
have revealed that
a large-scale regulatory crosstalk exists between the UPR and the other
intracellular signaling pathways. For example, the phosphoinositide 3-kinase (PI3K) pathway and
the mitogen-activated protein kinase (MAPK) pathways cross talk with UPR. However, the precise
extent and mechanisms of crosstalk have not yet been clearly defined. Therefore, it is still unclear
how the UPR pathways are connected to form networks, how specific information is processed
as it flows through intermediate components, and how the network is tuned by various regulatory
inputs. The dysfunctional UPR has been associated with the development of many neurological
and metabolic diseases such as diabetes, arthritis, and certain cancers. Consequently, a pressing
need is to better understand the UPR to explore the therapeutic interventions targeting the UPR
components for the treatment of these diseases.
The Ire1 pathway is the sole UPR pathway in the budding yeast S. cerevisiae. In this
proposal, we will use S. cerevisiae as a model organism to investigate the regulatory UPR network
that contributes to ER proteostasis. Here, we have delineated two specific aims, involving three
protein kinases: Pkh1 (human ortholog of PDK1, phosphoinositide-dependent kinase 1), Ypk1 [a
substrate of Ypk1, human ortholog of serum and glucocorticoid-regulated kinase 1 (SGK1)] and
Slt2 (human ortholog of MAPK ERK5). We will initially characterize the roles kinases Pkh1, Ypk1
and Slt2 in the yeast UPR mediated by Ire1. Building on our findings in yeast cells, we will
understand the roles of human PDK1, SGK1 and ERK5 in human UPR. Collectively, our study
will unveil a new biological nexus between the PI3K, MAPK and UPR pathways.

Public health relevance
We will conduct molecular and biochemical investigations into the unfolded protein response pathway (UPR), a cellular strategy that increases the ability of cells to fold proteins inside the endoplasmic reticulum. These investigations will deepen our understanding of UPR pathways, which could lead to identification of novel therapeutic targets. Additionally, this knowledge will help in designing combination therapies for various human diseases, such as Alzheimer and Parkinson’s diseases, as well as certain types of cancers.